FASEB SRC: Immunoreceptors and Immunotherapy

Abstract
The goal of this application is to secure funding for the 2022 FASEB summer research conference (SRC) on
“Immunoreceptors and Immunotherapy.” This long-running SRC began in 1987 and has continued to foster a
highly interactive community of researchers focused on solving important problems in immunoreceptor and
immunotherapy biology. Immunoreceptors play a central role in cancer, autoimmunity and infectious diseases,
whilst immunotherapy is the rapidly expanding field focused on meeting these challenges and changing people’s
lives in the clinic. The meeting program addresses new directions in the field by featuring the best science related
to immune receptor function, immune cell signaling, and the physiology and pathology of immune diseases. We
also highlight emerging topics including inhibitory receptors and antibody engineering, along with autoimmunity
and immune dysfunction and immunotherapy in cancer. Our speakers represent leaders in the field as well as
early- and mid-career investigators. The speakers have been chosen to feature cutting-edge aspects of
immunoreceptor and immunotherapy biology, covering the range from basic science to translational applications.
The program also includes state-of-the-art technologies in imaging, structural analysis, computational modeling
and therapeutic approaches. As such, this meeting brings together scientists from different fields, creating a
dynamic and interdisciplinary environment for building networks and developing collaborations. The FASEB SRC
provides an ideal format for this meeting, since interactions between participants is guaranteed by the size of
the meeting, multiple poster sessions and shared meals. The R13 will support additional opportunities for
trainees and young investigators to present at the conference with short talks and poster presentations. Other
networking opportunities, including a “meet the expert” luncheon and Career Workshop will further help to foster
connections between young investigators and senior researchers. With SRC program, we aim to encourage
intensive scientific discussion that promotes new interactions among the international community engaged in
immunobiology research.

Public health relevance
Narrative This application requests NIH support for a conference that brings together a highly interactive and collaborative community of scientists focused on solving important problems in immunobiology. This meeting will highlight the latest technological advances in immune cell research, with a focus on understanding immune receptor function as well as the complex interplay of immune cells that support an efficient immune response. This research is important to human health since it helps to drive new therapeutic strategies for harnessing the power of immune cells in targeting diseases, including autoimmunity, infectious disease and cancer.